Diversity Supplement - Rapid Actionable Data for Opioid Response in Kentucky (RADOR-KY)

Abstract
Opioid use disorder (OUD) is a major public health concern, with opioids being involved in
approximately 75% of the 107,622 overdose deaths reported by the Centers for Disease Control
(CDC) in 2021. Overdose rates have risen in recent years and substantial resources are
invested in combatting OUD at the national and local levels. Coordination of efforts to combat
OUD may be the key to reducing overdose deaths. To this end, the RADOR-KY project will build
a robust state-wide surveillance system, integrating diverse data sources to monitor and predict
drug overdose mortality and morbidity. This system will be used by stakeholders to inform data-
driven action, supporting the coordination and targeting of prevention and treatment efforts. As
proposed in the parent grant for this supplement, the RADOR-KY system will integrate several
data sources related to OUD prevention and treatment efforts. However, there are gaps in the
data that is available to RADOR-KY. Kentucky does not have an all-payer claims database and
so data about residential OUD treatment and treatment support systems can only be obtained
from Medicaid beneficiaries. In this proposal we will supplement the RADOR-KY efforts, using
an informatics approach to capture data about treatment and recovery support services funded
by the Kentucky Opioid Response Effort (KORE), a state-administered and federally funded
program aimed at reducing overdose death and expanding access to treatment and support
services. KORE funds treatment support services (e.g., peer support, recovery community
centers) and, for uninsured and underinsured people, medication and residential treatment.
KORE data is currently collected for reporting to the Substance Abuse and Mental Health
Administration, but the existing approach is unstandardized, leading to inefficiencies, delays,
and quality issues that make KORE data unsuitable for use in RADOR-KY. The specific aims of
this project are to build a new platform for KORE agencies to submit standardized data –
improving data ingestion through automated validation – and then to create near-real time
visualizations and analyses that will allow KORE agencies and other stakeholders to refine and
target their efforts to combat OUD. This data will be integrated into RADOR-KY, supporting the
aims of the parent grant by improving the surveillance database and predictive models. We will
share the code and methods developed for this project publicly, allowing other agencies within
and beyond Kentucky to improve their analytic and planning capabilities. This will be especially
helpful for administering State Opioid Response efforts in other states.

Public health relevance
Project Narrative This project will create a new system for capturing data from agencies receiving Kentucky Opioid Response Effort (KORE) funding to provide treatment and support services for people with opioid use disorder. Data will undergo automated validation and be used to generate near- real time insights about trends in service utilization. The data will also be used in the RADOR- KY surveillance ecosystem, expanding and improving the surveillance dashboards and predictive modeling used to coordinate and target resources for preventing overdose deaths.